Open-source software and hardware tools for local B0 field control

Project Summary/Abstract Multi-coil (MC) shim arrays have emerged as a promising and flexible tool for improving MRI image quality. Arrays of small, independently-driven loops placed close to the body provide an efficient way to generate rapidly-switchable magnetic field offsets (ΔB0) that can be shaped to provide useful field profiles inside the body. MC arrays were originally proposed for dynamically-switchable, high spatial order ?B0 shimming? in the body to null subject-specific perturbations of the static background B0 field. The improved shimming reduces geometric distortion in echo planar imaging (widely used for functional and diffusion MRI) and line broadening in MR spectroscopy. However, in the past few years, a surge of new uses for MC arrays have been proposed, including supplementary spatial encoding, improved lipid suppression, zoomed imaging, and reduced flip angle (B1+) inhomogeneity. This diverse and growing set of methods — which we classify as local field control — exploit two core features of MC arrays: (1) the ability of non-orthogonal ?B0 basis sets to generate field profiles that can not be created with linear gradients; and (2) the ability to rapidly update shim currents without causing artifacts. Unfortunately, MC local field control research has been slow to spread beyond a small handful of sites due to limited availability of instrumentation as well as control software. Commercial shim amplifiers with dynamic switching capability are rare, and those that do exist are cost-prohibitive for most applications (>$1,000/channel). At the same time, there is no readily-available software for controlling shim amplifiers and interfacing with the scanner host computer. Moreover, there is a lack of software tools using convex optimization to efficiently solve for shim current amplitudes for tailored local field control. We will break down these barriers to entry by developing an open-source resource called AFFECT (Automated Flexible Field Encoding and Control Toolkit). We will refine and disseminate our previously-validated low-cost ($100- 150/channel), low-voltage shim amplifier that is scalable up to 64-channels. We will also upgrade and package a graphical-user-interface (GUI) used to process B0 field maps and compute optimal shim currents. The GUI will be made modular to allow users to plug in their own custom shim optimization tools. Finally, we will create a seamless interface between the GUI and the scanner host computer to improve workflow. More than 10 research groups have already contacted us asking to use our open-source shim amplifiers. However, further work is required to prepare both the hardware and software for dissemination. The goal of this project is to translate our prototypes into robust, user-extensible tools that are packaged and documented. To expedite dissemination, we will provide up to 10 research groups with 32-channel amplifier setups free of charge. Users will also be free to download schematics and fabricate the circuit boards on their own.

Public health relevance
Project Narrative This project will create a packaged, documented, open-source suite of hardware and software tools to boost the productivity of multi-coil local field control research for MRI. The research community has seen a surge of interest in local field control methods, however the lack of available instrumentation and software has become a barrier for many investigators wishing to enter the research area. Building upon previously validated amplifiers and field optimization software developed by our group, we will put together a toolkit to help other researchers rapidly implement field control experiments. Expected to provide benefits for functional and diffusion imaging, which provide important functional and structural information about brain circuits. Another key application is magnetic resonance spectroscopy, which provides a molecular profile of tissues for assessing tumor malignancy and other applications.